Wildfire-specific particulate matter exposure during pregnancy and early life airway outcomes

PROJECT SUMMARY
Wildfires are an emergent environmental health threat in the U.S. as climate change contributes to increased
wildfire activity and severity. Wildfire smoke represents a growing contribution to overall fine particulate matter
(PM2.5), with distinct physicochemical properties that may lead to higher toxicity. Ambient PM2.5 is recognized to
adversely impact airway health, particularly among children. However, research on the early life respiratory
impacts of wildfire-specific PM2.5 is limited and predominantly focused on postnatal short-term exposure and
acute health effects. The potential impacts of prenatal exposure to wildfire smoke PM2.5 on early life airway
health remain largely unknown. In fact, there are currently no published studies of prenatal wildfire smoke
exposure and children’s airway health in prospective U.S. cohorts.
The proposed Aims will evaluate associations between prenatal wildfire-specific PM2.5 exposure and airway
outcomes in children under 24 months of age in the nationwide cohorts of the Environmental influences on
Child Health Outcomes (ECHO) Program (N~10,000). Aim 1 will evaluate risk of airway symptoms (wheezing
and asthma-related symptoms) and hospitalization (bronchiolitis and other acute respiratory infection)
associated with average smoke PM2.5 and days with smoke PM2.5 during pregnancy. Aim 2 will explore the role
of wildfire smoke exposure intensity, duration, and timing during pregnancy by evaluating how risk may vary in
association with “smoke days” of increasing intensity and “smoke waves” of increasing duration and intensity.
Aim 2 will also evaluate potential critical windows of exposure during different stages of fetal lung development.
Aim 3 will identify vulnerable sub-populations with disproportionate risk of airway outcomes by exploring effect
modification by fetal sex, geographic region, and neighborhood poverty rate.
This research will be among the first to evaluate associations between wildfire smoke exposure and child
airway health in the U.S., leveraging a geographically and socioeconomically diverse study population. The
proposal directly supports the mission of the National Institute of Environmental Health Sciences to advance
environmental health science, identify individual susceptibility, and conduct translational research to promote
environmental justice.

Public health relevance
PROJECT NARRATIVE Fine particulate matter (PM2.5) from wildfire smoke is a likely risk factor for child respiratory illness, yet the potential impacts of prenatal exposure to wildfire PM2.5 on child airway health are largely unknown. The proposed research will explore the impacts of gestational exposure to wildfire PM2.5 on airway symptoms and related hospitalization in children under 24 months of age in the nationwide cohorts of the Environmental influences on Child Health Outcomes (ECHO) Program. We will evaluate the role of exposure intensity, duration, and timing, and identify subgroups with disproportionate vulnerability to support evidence-based environmental policy and community interventions.